Deciphering the Mechanisms and Cellular Roles of Monomer-Driven Actin Dynamics

Project Summary
To divide, move, and communicate, cells rely on a dynamic actin cytoskeleton that can rapidly assemble and
change. This is achieved by the polymerization of actin monomers into filaments, the construction of filament
networks, and the disassembly of these networks back into monomers. Cells maintain a large monomer reserve
to meet the demands of actin network assembly. Because of its size, the monomer pool was traditionally
considered to be homogeneous. However, recent work by us and others has revealed distinct subgroups of
monomers that can drive and modify actin dynamics in ways that profoundly influence cell behavior. These
discoveries have shown us that the rules of monomer polymerization are much more complex than previously
thought. Addressing this severe knowledge gap in one of the most fundamental aspects of cytoskeletal biology
is paramount to understanding how actin functions in cells. It may also finally reveal why defects in monomer
regulation are associated with neurodegeneration, inflammatory disorders, cardiac disease and cancer.
Most of our current knowledge about actin monomer behavior comes from solution biochemistry. However, these
types of experiments cannot reproduce the complex monomer-driven actin dynamics seen in cells. Therefore,
we are devising strategies that merge biochemical principles with cellular imaging to reveal how monomeric actin
regulates the cytoskeleton in living cells. This includes controlling protein levels with micromolar precision, using
quantitative image analysis to extract rate constants and concentrations, and employing computational models
to reveal how cellular geometry influences actin dynamics. Additionally, we are developing new tools to describe
and quantify actin ultrastructure from super-resolution images. We will use these innovative approaches to
address the following fundamental knowledge gaps about monomer-driven actin dynamics: 1) How monomers
control the dynamics of complex actin networks, 2) How cell geometry contributes to monomer-regulated actin
dynamics, and 3) Novel roles for monomers in the regulation of cellular processes.

Public health relevance
Project Narrative Cells require their actin cytoskeleton to divide, move, and communicate with their environment. This project will reveal novel mechanisms of how actin monomers, the basic subunit the actin cytoskeleton, control the assembly and organization of actin structures in the cell. Deciphering these fundamental mechanisms could explain why defects in monomer regulation are associated with human diseases such as neurodegeneration, inflammatory disorders, cardiac disease and cancer.